BPA ORDER TITLED "EXTERNAL ENGAGEMENTS AND PARTNERSHIPS IN SUPPORT OF THE NHLBI MISSION" AGAINST THE NHLBI COMMUNICATIONS, ENGAGEMENT, AND EDUCATION SUPPORT SERVICES BPA II.

1) This BPA order supports Learn More Breathe Better® (LMBB). LMBB is a national health education program that aims to bring greater visibility to lung health by translating research for public and professional education programs. The program goal is to disseminate health education information to increase awareness about disease prevention and health promotion.